The Administrative Core for The San Diego Regional Network Award for Kidney, Urologic, and Hematologic Research Training

ADMINISTRATIVE CORE – PROJECT SUMMARY
This Administrative Core will support the adjoined U2C/TL1 application. The overall U2C/TL1 is designed
to comprehensively address and support research training in kidney, urology, and hematology research across
the San Diego region, and across the career continuum. The Administrative Core is led by a MPI team.
Francis Gabbai, an experienced administrator and nephrology investigator, and Jennifer Anger, who is Vice
Char for Research in the Department of Urology. The Administrative Core is designed to support the scholars
and faculty while facilitating budgeting and administrative processes to optimize use of time in research
endeavors for both the scholars and faculty, and to maximize, synergy, collaboration, and coordination across
KUH mission areas across the 3 participating institutions in San Diego. The Core is designed with 3 sub-units
for “Evaluation and Assessment”, “Communications”, and “Budget” sub-cores. It is also designed to serve as a
repository of information regarding performance and progress, thus all forms utilized to evaluate scholars and
faculty will be kept in a complete central repository. The Administrative Core is designed to deliver Aim 1 of
the overall U2C/TL1, which is “to provide outstanding administrative support, to facilitate coordination,
collaboration, and communication across the KUH mission areas and across the 3 partnering institutions, and
to provide comprehensive evaluation for continuous improvement efforts.”